Detecting Movement Onset During Closed-Loop Stimulation Using A Hidden Markov Model.

Project Summary/Abstract
No change from awarded project R01NS112424.

Public health relevance
Project Narrative No change from awarded project R01NS112424.